Integrated Systems Biology of Pediatric AML

ABSTRACT: Acute myeloid leukemia (AML) is a rare, devastating, and understudied malignancy with ~20,00 new cases
and around 61,000 cases in US. Though intensive chemotherapy primarily consisting of ara C (also known as cytarabine),
daunorubicin, and etopside have been used to treat AML for over 4 decades, only 65%, 40%, and 10% of pediatric (age
<21), adult (age 21-65), and elderly (age > 65) patients survive 5 years after diagnosis, respectively. Application co-PIs,
Drs. Lamba (pharmacology) and Pounds (biostatistician specializing in cancer genomics) have successfully collaborated
for over a decade to develop methods and discover molecular prognostic factors for AML. We and other investigators from
Children’s Oncology group have recently characterized the genome, methylome, and transcriptome of pediatric AML and
associated each of these with prognosis in pediatric AML. Dr. Pounds developed the innovative integrative analysis
procedure, canonical correlation with projection onto the most interesting statistical evidence (CC-PROMISE), that
dramatically increases statistical power for meaningful biological discovery in a rare-disease small sample size setting;
using CC-PROMISE, we discovered that reduced methylation and increased expression of the DNMT3B associates with
greater genome-wide methylation burden and worse prognosis; translating the DNMT3B discovery into evaluation of
demethylating agents in the ongoing AML16 clinical trial (NCT03164057). These genomic, epigenomic, and transcriptomic
features, along with microenvironmental and other factors, must impact the proteome and metabolome of AML in clinically
relevant ways which unfortunately are not well understood. There has been essentially no study focused on comprehensive
evaluation of the proteome and metabolome of pediatric AML in a reasonable cohort of uniformly treated patients. Noting
the marked genomic, transcriptomic, methylomic, and prognostic differences between pediatric and adult AML, it is not
plausible to extrapolate finding from adult AML patients to pediatric. Thus an integrated systems-level understanding of
the molecular disease biology is needed to develop effective strategies and improve the prognosis of pediatric AML. As
pioneers in the collection and integrated analysis of the pediatric AML genome, methylome, and transcriptome,
application co-PIs Drs. Lamba and Pounds are uniquely positioned to characterize the proteome and metabolome
of pediatric AML and integrate them with our large repository of previously collected molecular, treatment, and
outcome data for a series of multi-center clinical trials. Thus, in this application we propose to characterize global
metabolome (aim 1) and proteome (aim 2) the leukemic cell obtained at diagnosis for risk stratification and prognosis by
evaluating impact on outcome in three St Jude led multi-institute clinical trials (AML02, AML08 and AML16, total patients
n=400). In aim 3, we plan to develop a comprehensive integrated view of the genome, methylome, transcriptome,
proteome, metabolome, and clinical prognosis of pediatric AML using novel methods. These innovative and
exceptionally rigorous studies will be the first comprehensive evaluation of the pediatric AML metabolome and proteome
and develop an innovative integrated analysis method to perform the first integrated analysis of five forms of omic data with
multiple clinical endpoints to obtain the most complete understanding of pediatric AML systems biology to date.

Public health relevance
Relevance Statement: Acute myeloid leukemia (AML) is the second most common childhood leukemia and has a dismal prognosis. For over 40 years AML chemotherapy has changed little with the continued reliance on ara-C, daunorubicin and etoposide as frontline agents. The proposed research seeks to define the impact of proteomic and metabolomics landscape of leukemic cells on patient risk stratification and revealing additional layers of the molecular basis of AML prognosis to guide the development of more effective treatments for AML.